Synthesis Core

PROJECT SUMMARY: SYNTHESIS CORE
The Iowa Superfund Research Program (ISRP) at the University of Iowa investigates the sources and
exposure consequences of airborne polychlorinated biphenyls (PCBs), a class of Superfund chemicals. ISRP
biomedical and environmental research projects require a variety of study compounds ranging from technical
and synthetic PCB mixtures to pure PCB congeners and their metabolites for studies of the volatilization,
transport, exposure, toxicity, and remediation of these PCB congeners. One significant challenge of studying
PCBs is the sheer number of PCB congeners, which totals 209. Additionally, there exist 837 different
congeners for each class of PCB metabolite, including mono-hydroxylated (OH-PCBs), sulfated (OH-PCB
sulfates), and others. Most of these PCB derivatives are either not available from commercial sources or have
never been synthesized. Moreover, obtaining PCB mixtures or individual PCB congeners from commercial
sources can be expensive, especially in large quantities, and their independent authentication and confirmation
of purity are still necessary before use. To facilitate the innovative studies proposed by the ISRP research
projects, there is a critical need for a Synthesis Core (SC) that makes PCB mixtures, individual PCB
congeners, and their metabolites available for a broad range of studies on the volatilization, transport,
exposure, toxicity, and remediation of PCBs. The main objective of the SC, a small but critical and well-
integrated Research Support Core of the ISRP, is to address this need by providing a large variety of well-
authenticated and highly pure PCB mixtures and PCB derivatives in a timely and cost-efficient manner to all
research projects and research support cores within the ISRP. To attain this objective, the SC will: synthesize
and maintain a broad range of PCB derivatives, mostly using synthetic approaches developed in previous
funding cycles by SC researchers; employ rigorous guidelines established by ISRP researchers for the
authentication of these key chemicals; in collaboration with the DMAC, document the authentication of PCB
mixtures and PCB derivatives following the FAIR principles in appropriate repositories, and consult on the safe
handling PCBs and other hazardous chemicals. The Specific Aims of the ISRP Synthesis Core are to: 1)
Maintain and prepare PCB mixtures and pure PCB congeners; 2) Prepare methoxylated and hydroxylated PCB
derivatives; 3) Synthesize OH-PCB sulfate metabolites; and 4) Prepare miscellaneous compounds, including
diazomethane. The timely and cost-efficient availability of PCB mixtures, individual PCBs, OH-PCBs, OH-PCB
sulfates, and other PCB metabolites will enhance and, in some cases, enable the innovative studies proposed
by ISRP research projects. Moreover, the use of test compounds with well-documented authentication across
several research projects will improve the rigor and reproducibility of ISRP research.

Public health relevance
PROJECT NARRATIVE: SYNTHESIS CORE The Synthesis Core of the Superfund Research Program at The University of Iowa (ISRP) supports investigations of the consequences of sources and exposures to all airborne polychlorinated biphenyls (PCBs), an important class of Superfund chemicals, by providing PCB mixture, individual PCB congeners and PCB metabolites to ISRP researchers for laboratory studies and as analytical standards. The availability of authenticated test compounds in a timely and cost-efficient manner is relevant to the mandate of the Superfund Research Program because it will enable the innovative studies proposed by ISRP research projects and enhance the rigor and reproducibility of ISRP research.